Better Together: Integrating MOUD in African American Community Settings

Abstract
Racial disparities in engagement and retention in treatment with medication treatment for opioid use
disorder (MOUD) are profound and persistent and have devastating consequences. Black/African
American persons have experienced the fastest increases in opioid overdose deaths nationally since
2013 and now have higher rates of overdose deaths than whites. During 2020, the number of Black
persons dying from an opioid overdose increased by 45% compared to the previous year, nearly double
the increase for white overdose deaths. Despite the great need for MOUD, Black/African Americans
are less likely than whites to receive MOUD, especially buprenorphine, and have substantially lower
rates of MOUD treatment retention. Our own and others’ research identify that stigma, medical mistrust,
fear of legal consequences, and bias and misunderstanding about MOUD contribute to underutilization
of MOUD in Black/African American populations. To address these barriers, outreach, engagement,
and reengagement by community-based Peer Recovery Specialists ( trained individuals with shared
lived experience of SUD recovery), providing MOUD in a broader range of settings and by telemedicine,
and a collaborative care model integrating provision of substance use disorder treatment generally or
MOUD with buprenorphine in trusted, community sites, have been found to be feasible and attractive
to Black/African American persons with untreated OUD. We propose a multi-site hybrid implementation-
effectiveness trial to be conducted in Washington, DC, Chicago, and Miami/Dade County to evaluate:
1) implementation of the Integrated Collaborative Community MOUD care model (ICC-MOUD) and
2) the effectiveness of this model for improving 6-month retention in MOUD with buprenorphine among
currently untreated Black/African Americans with OUD compared to Medical Clinic-office-based
MOUD with buprenorphine (MC-MOUD). In ICC-MOUD, community sites serve as “spokes” for
telemedicine provision of MOUD by buprenorphine providers based in a “hub” buprenorphine clinic,
Peer Recovery Specialists will conduct outreach, engagement, and reengagement activities in the
community and serve as facilitators for telemedicine visits at the community site, and a community
health worker trained to serve as a Recovery Guide will provide on-site psychoeducation and behavioral
counseling to promote retention in care, medication adherence, and behavioral change. In MC-MOUD,
participants are referred to and treated entirely in a MOUD clinic/office.

Public health relevance
Project Narrative: The study has two phases. Phase, I in years 1 and 2, will consist of qualitative interviews to community stakeholders to better understand the population of African American Opioid Use Disorder users in the target neighborhood and their barriers to treatment. There will also be a focus in understanding the population and the community providers view of medication for Opioid Use Disorder. Finally in Phase 1, the Community Advisory Board will be established, personnel hired and trained and feasibility established. In the second phase of the study, Years 3-5, effectiveness of the Integrated Collaborative Community MOUD care model (ICC-MOUD) will be investigated by comparing it to treatment as usual, the Medical Clinic or office-based MOUD with buprenorphine (MC-MOUD). The study will also evaluate the barriers and facilitators to implementation of ICC- MOUD.